Development of deazaflavin analogs as potent and selective MRP1 inhibitors for cancer chemosensitization

Project Summary/Abstract
Resistance to chemotherapy is a major contributor to cancer relapse and treatment failure. Of many molecular
mechanisms of cancer therapeutic resistance, increased drug efflux, mediated by ATP-binding cassette
(ABC) transporters, results in multidrug resistance (MDR) and poses a huge barrier to effective cancer
therapy. Small molecule inhibitors of efflux could be used to sensitize cancer cells toward chemotherapeutic
treatment and improve treatment quality. Significantly, we have identified a highly potent lead compound, a
deazaflavin analog which at single digit nanomolar concentrations drastically increased the intracellular
concentration of etoposide (ETP), and to a lesser extent, that of teniposide and pemetrexed, all are important
cancer chemotherapeutics. Our prior studies revealed that it is a potent inhibitor of MRP1. Notably, it displayed
excellent selectivity over other major ABC transporters, including P-gp, BCRP, MRP2 and MRP3, and fully
reversed the MRP1-mediated drug resistance to ETP and doxorubicin in H69AR small cell lung cancer cells.
In addition, it exhibited desirable PK in preliminary mice testing without altering distribution of co-administered
ETP to normal tissues in healthy mice, and hence may have limited toxicological consequences. These
preliminary findings strongly suggest this lead and its analogs could be a highly valuable lead series for
developing combination treatments with clinical TOP2 poisons or other anticancer drugs. The objectives of
this grant application are to examine a library of deazaflavin analogs for MRP1 inhibiting activity and to further
evaluate their potential for cancer chemotherapy sensitization in in vitro and in vivo models, by pursuing these
specific aims: Aim 1. to screen and characterize deazaflavin analogs for MRP1 inhibition using membrane
vesicle-based and cell-based drug transport assays. In this aim, we will screen an in-house deazaflavin analog
library (~30 synthetic analogs) using vesicular transport assay and cell-based calcein retention assay for
MRP1 inhibitory activity and characterize their potency, selectivity as well as examine the structure-activity
relationship (SAR). We will also perform site-directed mutagenesis on MRP1 to identify residues that may be
critical for the inhibitory effect of the analogs. Aim 2. to evaluate the deazaflavin analogs for cancer chemo-
sensitization in in vitro and in vivo models. In this aim, we will first evaluate advanced analogs for chemo-
sensitization in a panel of lung cancer and neuroblastoma cells toward selected chemotherapeutics and
establish correlations to the MRP1 protein expression and inhibition. We will then profile the in vivo toxicity of
our top analogs in mice, and further evaluate the anti-tumor effect and toxicological consequence of the
analogs in combination with TOP2 poison ETP in a xenograft mouse model of multidrug resistant lung cancer.
At the conclusion of the studies outlined in this proposal, a better understanding of the mechanism of action
and the chemotherapeutic sensitizing potential of our lead compounds will be gained, which will lay a solid
foundation for future preclinical studies.

Public health relevance
Project Narrative Transporter-mediated drug efflux is a major mechanism of cancer multidrug resistance (MDR) and poses a huge barrier to effective cancer therapy. Small molecule inhibitors of efflux could be used to sensitize cancer cells toward chemotherapeutic treatment and improve treatment quality. The aim of this project is to screen an in-house deazaflavin analog library and characterize the molecular mechanism and sensitizing potential of our lead efflux inhibitors.